Investigating selective regional and neuronal disease vulnerability in Spinocerebellar Ataxia Type 2

PROJECT SUMMARY:
Neurodegenerative disorders manifest selectively in particular neuronal populations and brain regions, through
mechanisms we do not yet understand. Spinocerebellar Ataxia Type 2 (SCA2) is a fatal, hereditary
neurodegenerative disorder caused by expansions in the CAG nucleotide repeat region of the ATXN2 gene,
causing a gain-of-function ATXN2 protein with neurotoxic properties. While ATXN2 is expressed throughout the
CNS, only a subset of brain structures and neurons are vulnerable to gross atrophy and cell death. The
cerebellum is highly affected, resulting in the loss of voluntary movement, motor coordination, and speech
difficulties in SCA2 patients. Across disease progression, there is pronounced cerebellar degeneration and
selective loss of cerebellar Purkinje cells. Cerebellar degeneration occurs anterior to posterior, with the most
posterior regions resistant to neurodegeneration. Multiple genetic and environmental insults also cause anterior
to posterior cerebellar atrophy, suggesting that a conserved mechanism underlies the neurodegeneration
gradient. To date, the cellular and molecular mechanisms underlying the variable cerebellar and Purkinje cell-
specific vulnerability in SCA2 have not been investigated. I hypothesize that regional cerebellar vulnerability
in SCA2 is modified by differential expression of neuroprotective pathways in response to cellular stress
and disease. I will address this hypothesis in the following specific aims. In Aim 1, I will test whether Hspb1, a
gene enriched in the posterior cerebellum, and previously identified as neuroprotective in other cerebellar
degenerative disorders, can contribute to the protection of Purkinje cell loss in a mouse model of SCA2. If so,
this will further support a conserved mechanism underlying the degenerative pattern and suggest common
therapeutic avenues. In Aim 2A, I will identify novel neuroprotective pathways in a SCA2 model with the use of
high throughput single-cell RNA-sequencing of the cerebellar transcriptome at fine temporal and spatial
resolution. In Aim 2B, I will specifically address regional Purkinje cell vulnerability in SCA2 through the use of
cell-type-specific ribosomal profiling to assess differential gene expression between disease-vulnerable and -
resilient Purkinje cell populations. By comparing differential gene expression between the anterior and posterior
cerebellum in both Aim 2A and Aim 2B, I will identify novel genetic modifiers of disease vulnerability for future
validation. This study will be the first to characterize SCA2 degeneration and disease progression at a single-
cell spatiotemporal resolution. As there is no effective treatment available for SCA2 patients, understanding the
factors that protect against neurodegeneration and cell-type-specific contributions to disease pathology will help
to better inform future therapeutic interventions.

Public health relevance
PROJECT NARRATIVE: Spinocerebellar ataxia type 2 a progressive and fatal degenerative disorder caused by expanded trinucleotide repeats of “CAG” in the ATXN2 gene. It primarily affects the cerebellum, a region of the central nervous system that is important for voluntary movement and motor coordination, functions which are lost in patients over time. The proposed research aims to investigate differences in the vulnerability of specific subregions of the cerebellum to degeneration, in order to identify genes and cellular pathways whose function may be protective and further the development of more targeted therapeutics for patients.